NOCTURNAL TSH SURGE IN CENTRAL HYPOTHYROIDISM

In this study, 60 childrens with idiopathic short stature undergo overnight study of their pattern TSH. In addition, 60 children who have undergone treatment of CNS tumor/oncology and 60 children who have survived significant head injury will be studied. Those who are identified as having blunted TSH secretion at night will be eligible to participate in a subsequent placebo-controlled treatment phase.